JAK/STAT Regulation of Macrophage-mediated Inflammation in Diabetic Wound Repair

PROJECT SUMMARY/ABSTRACT
Non-healing wounds in diabetes are the leading cause of lower extremity amputations and are associated
with significant morbidity and mortality. Currently, there is an unmet need for more effective therapies, since
existing treatments leave nearly 70% of diabetic wounds unhealed. Thus, a critical need exists for understanding
the pathophysiology of wound healing and identifying more effective treatment strategies for patients with
diabetic wounds.
Following injury, monocyte-macrophages are recruited to the wound where they transition from a pro-
inflammatory to an anti-inflammatory phenotype; an essential switch that is necessary for tissue repair. However,
in diabetic wounds, macrophages fail to transition to an anti-inflammatory, reparative phenotype, thereby leading
to an overall pro-inflammatory state that results in impaired wound healing. Although epigenetic mechanisms
have been shown to regulate Mφ phenotype in wounds, the regulation of these epigenetic pathways in diabetic
wounds remains unknown. Our preliminary data identifies that JMJD3, a histone demethylase that selectively
demethylates histone 3 at lysine 27 (H3K27), increases inflammatory gene transcription and is increased in
murine and human diabetic wound macrophages. Further, we found that JAK1-STAT3 signaling may regulate
Jmjd3 transcription in wound Ms. Considering these findings, we hypothesize that increased JAK1-STAT3
signaling induces Jmjd3 in diabetic wound Ms and upregulates inflammatory gene expression. Further,
we postulate that inhibiting JMJD3 or JAK1,3 in diabetic wound Ms improves tissue repair. This hypothesis will
be investigated through the following specific aims: 1) To identify the JAK1/STAT3-mediated mechanism(s) that
regulate Mφ-specific Jmjd3 expression in normal and diabetic wound tissue and human monocytes. 2) To
determine the effects of JAK1,3 and JMJD3 inhibition on diabetic wound Mφ polarization and tissue repair.

Public health relevance
PROJECT NARRATIVE Non-healing diabetic wounds are the most common cause of amputation in the United States with a 5- year mortality of nearly 50% and annual cost to the healthcare system of $19 billion. This study will examine how increased JAK/STAT signaling in diabetic wounds polarizes macrophages in the wound towards a pro- inflammatory phenotype that promotes chronic inflammation and non-healing and how blockade of JAK and JMJD3 will decrease inflammation and improve healing in diabetic murine wounds. The success of the human and animal studies outlined in this proposal may lead to improved understanding of the pathophysiology of non-healing diabetic wounds and test novel therapeutic targets and allow me to develop as a clinician-scientist.